Admin supplement - Autism in young children with Down Syndrome

Abstract
Down syndrome (DS) is associated with an elevated likelihood of co-occurring psychiatric conditions, including
autism spectrum disorder (ASD). At present, little is known regarding the mechanisms that underly co-occurring
DS and ASD. Advancing the scientific knowledge base in this area could facilitate the potential discovery of
measurable biomarkers associated with early identification of ASD risk and also inform groundbreaking
biomedical treatments targeting underlying molecular processes. This Administrative Supplement will expand
the scope of parent project #R01HD110542 (Autism in Young Children with Down Syndrome) to identify early
biosignatures associated with early ASD-related dimensions in young children with DS. To do so, this project will
build on the parent study’s prospective design by collecting blood samples concurrently with study visits, and
examine the link between early ASD features and multi-omics signatures in the transcriptome, proteome, and
metabolome. Findings from the proposed Administrative Supplement project could facilitate the potential
discovery of measurable biomarkers associated with early identification of ASD risk and inform groundbreaking
biomedical treatments targeting underlying molecular processes. This study expansion will directly address the
NIH INCLUDE objective of identifying the “unique combination of risk and resiliencies [to] inform medical
advances for individuals with Down syndrome” and to improve health and well-being in this population.

Public health relevance
Narrative This Supplement project aims to identify molecular markers of risk for autism spectrum disorder (ASD) in young children with Down syndrome (DS) to advance early screening procedures. We will leverage the ASD-related phenotyping data collected in project #R01HD110542 and collect blood samples concurrently with ASD assessment visits. The addition of biospecimen collection to parent project data collection could facilitate the discovery of molecular indicators of ASD in DS and advance early detection of DS+ASD. It could also identify potential mechanisms that contribute to the onset of DS+ASD and contribute to a new scientific foundation for early intervention and future treatments in this population.